COVID-19 Preventive Health Inventory: Evaluating a primary care approach to catching-up on needed chronic and preventive care for Veterans

Background: Chronic disease and preventive care that occurs within primary care was delayed or deferred in
the acute COVID-19 crisis, which is expected to have profound impacts on the health of VA patients. In
response, the VHA Office of Primary Care (OPC) launched the Preventative Health Initiative (PHI) on March
1st, 2021 to support primary care in delivering needed primary care services. This innovative care coordination
intervention leverages three main components: 1) development of an electronic dashboard utilizing 10
common chronic and preventive care quality measures; 2) using nurse care managers for proactive virtual care
visits; and 3) the use of structured electronic health record note template to complete needed care. Our current
work has shown substantial PHI use and diffusion; however, little is known about implementation and
outcomes from PHI uptake. Our proposal will address these knowledge gaps and provide needed evidence on
mitigation strategies being supported by the OPC.
Significance/Impact: This study will build on ongoing collaborations between VA’s OPC and health services
researchers and provide needed evidence that the VA health system can use to better serve Veterans in
ongoing pandemic response and recovery. A key component of our work will assess whether national efforts to
mitigate effects of the pandemic were effective in reducing adverse health impacts.
Innovation: Our work will be the first to evaluate the implementation of a multi-component care coordination
intervention to support chronic and preventive care after the disruption to primary care delivery caused by the
pandemic.
Specific Aims: Aim 1: Identify key factors associated with use of PHI at 1 year as a care coordination
intervention to improve coordination of chronic and preventive disease in primary care Aim 2: Understand
implementation of the PHI to deliver chronic and preventive care from the perspectives of a) clinic frontline staff
(leaders, PCPs, and nurse care managers) and b) Veterans who received the PHI. Aim 3: Examine impact of
PHI tool on primary care quality (diabetes, hypertension, and colon cancer screening) and potentially
preventable utilization.
Methodology: This rapid-cycle evaluation will use both quantitative and qualitative approaches to
understanding the implementation and outcomes from the OPC’s PHI intervention. Aim 1: We will use a multi-
level modeling approach to examine patient-level variation in rates of PHI-use to identify the extent to which
Veteran, provider, or clinic-factors explain this variation. Aim 2: We will conduct semi-structured interviews
among clinic staff to understand the implementation of PHI and Veteran experience of PHI-directed care. Aim
3: We will conduct a propensity scored matched analysis, matching patients who received PHI intervention to a
comparison group who did not receive PHI to estimate the impacts on quality and utilization measures using a
series of difference-in-differences regression models.
Implementation/Next Steps: Together, work from these aims will provide key evidence for VA policymakers
on the impact of a large-scale care coordination intervention on mitigating the impact COVID-19 on chronic and
preventive care.

Public health relevance
COVID-19 pandemic dramatically disrupted primary care causing profound impacts on morbidity and mortality related to chronic and preventive disease care. Department of Veterans Affairs (VA) Office of Primary Care (OPC) provides primary care to over 6 million Veterans and is responsible for mitigating the effects to chronic and preventive care caused by these disruptions. On March 1st 2020, OPC launched a multi-component care coordination intervention called Preventative Health Inventory (PHI). Early data suggests increasing adoption across the VA. However, significant knowledge gaps remain around PHI implementation and outcomes. Our proposal is a rapid-cycle evaluation aimed to fill these knowledge gaps and support OPC in mitigating the impact of COVID-19 on chronic and preventive care.